Atherosclerotic Risk of Branched Chain Amino Acids in a Tissue Engineered Blood Vessel Model

Elevated levels of the branched chain amino acids (BCAA) leucine, isoleucine, and valine are highly correlated
with the development of CVD and adverse cardiovascular events, such as heart attacks. Some mechanisms
linking BCAA, metabolic disease and heart failure have been documented. However, it remains unclear if
BCAAs directly interact with vascular cells to enable CVD onset and progression. Mouse models that have
been developed to study CVD and BCAA both have limitations in their applicability to human physiology.
Current in vitro models of atherosclerosis are limited to early stages of atherogenesis, and it is challenging to
recapitulate more advanced atherosclerotic changes. To address this issue, we will develop a model of an
intermediate atherosclerotic lesion using a human tissue engineered blood vessel system (TEBV) model with a
disease-pathology collagen extracellular matrix enriched with the glycosaminoglycan chondroitin sulfate (CS),
treated with modified low-density lipoprotein (LDL). We will use collagen TEBVs treated with modified LDL as a
model for early atherosclerosis. These platforms will be used as a platform to study BCAA mechanism in CVD.
The TEBV model is made of collagen or CS-collagen vessels with encapsulated human neonatal dermal
fibroblasts serving as the medial cells in the vascular wall and an endothelialized inner lumen of endothelial
colony-forming cells (ECFCs). It is perfused with medium at a rate of 2 mL/minute and can be cultured for up to
6 weeks. We have demonstrated that the CS-enriched vessels have an enhanced sensitivity to the
inflammatory effects of modified LDL and demonstrate increased vessel vasoactive dysfunction and
endothelial-leukocyte interactions compared to collagen TEBVs. We have also demonstrated that elevations of
the BCAA within the physiological milieu are sufficient to induce an atherosclerotic phenotype in the
endothelium. Preliminary results demonstrate that treatment of ECFCs with elevated BCAA and oxidized low-
density lipoprotein causes increased mitochondrial oxidative stress, as well as decreased expression of LC3B,
an autophagosome protein. This induced early atherosclerotic events in the TEBV system: impaired
endothelium-controlled vasodilation and leukocyte adhesion to the endothelium. Autophagic flux will be further
assayed via Western Blot for LC3-I to LC3-II conversion. Vascular cells, especially the endothelium, may be
sensitive to the effects of elevated BCAA because they do not significantly contribute to BCAA metabolism,
leading to intracellular buildup of metabolites and mitochondrial stress. This will be tested via metabolomic
analysis of BCAA and their downstream metabolites in the vascular cells. Using the TEBVs, we will determine
the role of BCAA in early versus intermediate atherosclerosis. At the end of the study, we will have an
intermediate lesion model of atherosclerosis, the mechanisms linking BCAA to cardiovascular events will
become clearer, and potential therapeutic targets for atherosclerosis will be identified.

Public health relevance
Recent research has shown that elevated levels of a class of molecules in the blood called branched chain amino acids are correlated with the development of heart disease, but we are currently unsure of why this occurs and how we could prevent their harmful effects. We propose to use a unique tissue engineered blood vessel system made of human cells to study how branched chain amino acids affect vascular cell health on a molecular level. This will help us understand why branched chain amino acids are associated with heart disease and potentially inform us on how to treat heart disease with new therapies.